Structure, Function and Drug Treatment of the Native Cardiac Sarcomere in Hypertrophic Cardiomyopathy

PROJECT SUMMARY
Hypertrophic cardiomyopathy (HCM) is the most common genetic cardiovascular disorder. Over 35% of the ~400
mutations identified in HCM patients occur in the motor protein β-myosin. In vitro studies of the R403Q mutant
β-myosin revealed hypercontractility of myosin cross-bridge dynamics, including increased ATP turnover and
more myosin molecules in the disorganized relaxed sate (DRX) that enables excessive β-myosin contributions
to ventricular contractions. When treated with the only FDA-approved HCM-drug mavacamten, the biochemical
and structural properties of the isolated mutant β-myosin resembled the WT control. However, direct observation
of β-myosin’s conformational alterations due to HCM inducing mutations or mavacamten treatment have yet to
be observed in situ. Cryo-electron tomography (cryo-ET) is a powerful imaging technique that enables the
visualization of several native cellular macromolecular structures inside intact cells, such as intact myofibrils from
cardiomyocytes. However, many of the cryo-ET studies of muscle have been limited to isolated subcellular
structures in vitro rather than intact, unperturbed (cardio)myocytes. Additionally, studies often immersed the
isolated contractile machinery in conformation inducing buffers before plunge freezing and cryo-ET, possibly
further altering the native ratio of myosin active and inactive states. There is a direct need to identify if the
isolation procedures utilized to obtain myofibrils result in similar β-myosin structural characteristics found in situ.
Further, accurate depiction of native wild type cardiac β-myosin structural features are required to accurately
understand how pathological mutations and treatments influence and affect cardiac function and health. To view
these contractile proteins within their cellular context, technically difficult high pressure freezing (HPF) and cryo-
focused ion beam (cryo-FIB) milling is needed to ensure pristine vitrification of the cells and their organelles.
Few labs worldwide have successfully implemented an HFP/cryo-FIB milling/cryo-ET workflow for intact
eukaryotic cells and tissues in their native state, including the lab of Dr. Daniela Nicastro, the sponsor of this
application. Therefore, I aim to determine the native in situ structure of myofibrils within intact inducible
pluripotent stem cell derived human cardiomyocytes using high pressure freezing, followed by cryo-FIB
milling to generate thin lamellae that can be imaged by cryo-ET. I will apply this cryo-ET workflow also to
characterize structural alterations that occur within sarcomeres due to β-myosin mutations with and
without mavacamten treatment. Determining the structural alterations that occur due to mutant β-myosin and
mavacamten treatment will provide important insight for future improvement and development of therapeutics
able to improve the health of myopathy patients.

Public health relevance
PROJECT NARRATIVE The heart’s ability to produce contractile force relies on millions of β-myosin motor proteins that assemble into thick filaments within sarcomeres, which is the functional unit of cardiac muscle cells. Genetic mutations in these motor proteins can result in severe hypertrophic cardiomyopathy and we lack a complete understanding of how myosin proteins are organized inside the muscle cells and how they respond to new pharmacological treatments. This study will use the cutting-edge imaging technique cryo-electron tomography to reveal the native in situ structure of β-myosin in healthy and diseased cardiomyocytes, and characterize how β-myosin mutations and mavacamten treatment affect β-myosin structure and function.